Core C: Biostatistical and Bioinformatics Core

The Biostatistics and Bioinformatics Core (Core C) facility will provide study design, pipeline development, data management, and computational support for all SPORE in Pancreas investigators and projects. The Biostatistics component of the Core will perform consultation and collaboration on all aspects of statistical study design, database development and quality control, and data analysis and interpretation. The Bioinformatics component of the Core will perform consultation and collaboration on all aspects of genomics and bioinformatics study design, pipeline development, omics data integration, visualization, interpretation and genomic data sharing through controlled access systems. Core C will provide bioinformatics and biostatistics collaborations for SPORE projects, Developmental Research Program (DRP) studies, and other Cores to ensure that robust statistical methods and robust reproducible omics analyses are available to support SPORE investigators. Core C will also provide bioinformatics and biostatistical support and training to junior investigators through the Career Enhancement Program (CEP). The Biostatistics and Bioinformatics components of Core C will work together closely to ensure their efforts are integrated and complementary.

Public health relevance
The development and application of new computational methodology for cancer research has expanded roles for statisticians and computational experts. The Biostatistics and Bioinformatics Core provides the statistical, bioinformatics, and computational support for all SPORE in Pancreatic Cancer investigators. Core C will support consultation and collaboration on all aspects of study design, database development and quality control, and data analysis, interpretation, and presentation of data.